Neutrophils and Monocytes in Pediatric Ischemic Stroke

PROJECT SUMMARY (Description)
Ischemic stroke affects around 1 in 1600 to 4000 births, has the highest incidence in neonates and infants (<
one year of age), and may cause neurological sequalae, including motor and cognitive deficits. Infection and
immune responses are a major risk factor for pediatric stroke, but no immune-directed therapies are available.
In fact, supportive measures remain the mainstay of pediatric stroke care, since the lytic treatment carries a
high in neonates with fragile cerebrovascular vessels. In this project, we will use a murine model of pediatric
stroke, with and without lipopolysaccharides (LPS)-sensitization, to test the pathological roles of neutrophils
and monocytes towards the development of immunomodulation therapies.
Aim 1: To clarify how immune cells breach the pial/glia limitans barrier in pediatric LPS/stroke. We will use flow
cytometry and single-cell RNA-Seq analysis to determine the compositions and transcriptome of immune cells
in the meninges after LPS/stroke, and test whether anti-MMP9 treatment prevents the neutrophil influx.
Aim 2: To test whether there are two waves of monocytic infiltrates with distinct functions in pediatric stroke. We
will use CCR2-CreER mice to track monocytic infiltrates and single-cell RNA-Seq analysis, as well as, block the
influx of monocytes at different stage after stroke to address this issue.
Aim 3: To determine what constitutes the meninges-incurred pathogenicity of neutrophils after pediatric
LPS/stroke. Our RNA-Seq results suggest that neutrophils acquire IL-36gamma, a novel family of the IL-1
family cytokine, in the meninges. We will validate these findings and test the benefits of anti-IL36R treatment.
Successful completion of this project will shed insights into the mechanisms of pediatric ischemic stroke and
whether neutrophil/monocyte-targeted immunomodulation therapies could provide better clinical management.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (Narrative) Pediatric stroke has the highest incidence in neonates or infants, and may cause severe neurological sequalae, including motor and cognitive deficits. Infection and immune responses are a major risk factor for pediatric stroke, but no immune-directed therapies are available. The goal of this project is to test the pathological functions of blood-borne neutrophils and monocytes in experimental pediatric stroke to develop immunomodulation therapies of this condition.